Research Project 1 - Allerton

Project Summary
Heart failure with preserved ejection fraction (HFpEF) will soon become the predominant form of heart failure.
Patients with cardiometabolic HFpEF have multiple co-morbidities including obesity, hypertension, and diabetes.
The primary symptom of HFpEF is exercise intolerance. Skeletal muscle metabolic dysfunction and
hypoperfusion are cited as major causes of exercise intolerance in HFpEF. Patients with cardiometabolic HFpEF
have worse exercise intolerance and survival outcomes than people with other forms of HFpEF. Hydrogen sulfide
(H2S) is a gaseous signaling molecule important for metabolic and cardiovascular health. In skeletal muscle, 3-
mercaptopyruvate sulfurtransferase (3-MST) in myocytes produces mitochondrial H2S, while cystathionine-γ-
lyase (CSE) in the endothelium supplies microvascular H2S. Our preliminary studies demonstrate in patients and
animals with HFpEF severe H2S dysregulation. In humans with HFpEF, circulating plasma H2S bioavailability is
reduced by 80%. Animal models demonstrate a similar reduction in circulating H2S but also show a significant
reduction in skeletal muscle H2S along with a reduction in the expression of the H2S-producing enzyme 3-MST.
The loss of H2S induces metabolic inefficiency in metabolizing important fuels for exercise. H2S donor therapy
increases H2S bioavailability and restores skeletal muscle metabolic function in animal models of HFpEF. These
preliminary studies demonstrate that H2S is involved in the physiological response to exercise in HFpEF. Our
central hypothesis is that reductions in H2S synthesis and bioavailability lead to impaired skeletal muscle
metabolism and exercise intolerance in cardiometabolic HFpEF. Using novel H2S detection methods we will
investigate the impact of skeletal muscle 3-MST and endothelial cell CSE on exercise intolerance during
progression of cardiometabolic HFpEF. We will determine the role of H2S on skeletal muscle metabolism and
mitochondrial function during cardiometabolic. The long-term objective of our proposed studies is to understand
how H2S contributes to skeletal muscle function and metabolism in HFpEF.